Dissecting the functional organization of local hippocampal circuits underlying spatial representations

Project Summary
The research proposed in the R00 phase will be conducted in the Department of Neuroscience at Yale University School of Medicine. The project description has been updated to reflect changes in the research from the original submission.
The ability to remember past personal happenings to guide proper behavior and make correct decisions is essential to our everyday life. Memory transience observed in neurodegenerative disorders such as Alzheimer’s disease has severe afflicting implications. Hippocampal circuits have long been posited to mediate spatial information necessary for episodic memory processes. At the cellular level, a striking and behaviorally relevant form of spatial information can be found in the receptive fields of CA1 place cells which collectively produce a representation of the external world. However, it remains unknown how hippocampal circuits operate to give rise to these representations, coordinate their output at the population level and broadcast this information to the rest of the brain. Addressing these questions would serve as a major step towards a deeper mechanistic understanding of the hippocampus and allow for the development of targeted approaches to prevent the devastating consequences of hippocampal circuit dysfunctions in various brain disorders.
In this proposal, I will leverage new electrophysiological, imaging, tracing and optogenetics methods to interrogate the functional organization of hippocampal circuits across multiple scales in awake behaving mice. The research plan is organized in three aims, split across a K99 training phase and a R00 independent phase. In the first aim (K99), I will initiate monosynaptic retrograde rabies tracing from a single CA1 neuron and record the activity of its inhibitory presynaptic partners with volumetric random access 2-photon calcium imaging during behavior. This will allow me to directly test the contribution of local inhibition on sculpting the input/output function of individual pyramidal cells. In the second aim (K99/R00), I will use patterned optogenetics manipulations with single-cell precision to produce network wide circuit maps between principal neurons and distinct inhibitory cell types. I will use it to identify core circuit motifs shaping the CA1 network structure and regulating the circuit’s specialized operations. In the R00 portion of the award, I will test whether the local organization of CA1 circuits helps dispatching and transferring spatial representations to brain regions downstream of the hippocampus.
During the K99 phase, the work was conducted in the Zuckerman Mind Brain Behavior Institute at Columbia University under the supervision of Drs. Attila Losonczy, Stefano Fusi, Liam Paninski, Darcy Peterka and Ashok Litwin-Kumar.

Public health relevance
PROJECT NARRATIVE Neural activity patterns in the hippocampus are known to support spatial and contextual representations in the brain, critical for episodic memory formation. The goal of this project is to understand how the circuit computations of functionally arranged inhibitory and excitatory hippocampal neurons can support these functions. I will use state-of-the-art single-cell tracing, optogenetics perturbations and imaging to characterize the fine-scale structure of hippocampal networks embedded into local and brain-wide circuits, and their role in coordinating response properties across the neuronal population. This work will be a crucial step towards a better understanding of the physiological basis of memory.